NK cell-mediated regulation of humoral immune responses during autoimmunity

ABSTRACT
Systemic lupus erythematosus (SLE, lupus) is a devastating autoimmune disease driven by pathogenic
autoantibodies that promote tissue injury. The autoantibodies are produced by dysregulated germinal center
(GC) B cells and Age-associated B cells (ABCs) receiving inappropriate differentiation, survival, and
proliferation signals from CD4+ T follicular helper (Tfh) cells. The molecular and cellular events that lead to
lymphocyte dysregulation during lupus are complex and still not well understood. Emerging data suggest that
Natural Killer (NK) cells, best known for their ability to kill infected and malignant cells, play important roles in
restricting excessive Tfh cell and B cell responses during infection. In viral infections, depletion of NK cells has
been shown to increase Tfh cells, GC B cells, and anti-viral antibodies. Whether NK cells regulate humoral
responses during lupus remains unclear. However, circulating NK cells are dysfunctional and significantly
reduced in SLE patients with active disease, and this reduction coincides with increases in circulating Tfh cells
and B cells and elevated autoantibody titers. We hypothesize that NK cells are important negative regulators of
pathogenic humoral responses during lupus, with specific roles in restricting disease-driving Tfh cell and B cell
populations. Accordingly, we will dissect the effects of NK cell, Tfh cell, and B cell interactions on autoantibody
production and disease progression during lupus. In Aim 1, we will investigate the role of NK cells in restricting
Tfh cell, GC B cell and ABC responses at different stages of lupus disease in mice. Aim 2 will assess the direct
cellular and molecular interactions that underlie NK cell-mediated regulating of humoral immune responses
during lupus. Finally, Aim 3 will test novel therapeutic agents designed to promote NK cell-mediated killing of
Tfh cells and B cells for potential therapeutic use in lupus. These studies are expected to critically advance our
understanding of how NK cell dysfunction impacts pathogenic Tfh cell and B cell responses in autoimmunity.
Ultimately, this information could provide new therapeutic targets to dampen adaptive immune responses in
autoimmunity.

Public health relevance
NARRATIVE Understanding how Natural Killer cells interact with pathogenic B cells and T cells has functional consequences in the progression of autoimmune disease. This study explores NK cell-mediated regulation of autoantibody responses in lupus and may provide new targets for future therapeutics.